Advanced 3D auxetic biodegradable implant for large volume breast reconstruction

Abstract
Breast cancer remains the most prevalent cancer in women worldwide, requiring surgical
interventions for tumor removal and subsequent breast reconstruction. The current predominant
breast reconstruction using non-biodegradable silicone or saline implants have a high risk of
complications, including fibrous capsule formation, pain, deformity, and even implant rupture.
While a number of tissue engineering approaches using biodegradable scaffolds have recently
emerged as an alternative to address the current challenges, current outcomes have
demonstrated limited volume of the regenerated adipose tissue due to a lack of vasculature
ingrowth.
A novel auxetic architecture with high flexibility, non-linear stiffening behavior, and
permeability, was recently developed for large volume soft tissue engineering. The primary
hypothesis of this research is that scaling up the geometric design of the auxetic architecture
design will further enhance its structural, mechanical, and biological performance, in terms of
flexibility, durability, permeability, and tissue regeneration capability for large volume breast
reconstruction. In Aim 1, the scaled-up auxetic designs will be characterized in comparison with
the original design through in-depth investigations including Finite Element (FE) simulation, µCT
analysis, and mechanical testing to demonstrate its biomechanical properties directly
comparable to the native adipose tissue. In Aim 2, the biological performance of the scaled-up
auxetic designs will be examined in comparison with the original design. This involves
assessment of cell viability and functionality of adipose-derived stromal cells (ASCs) in vitro
using large volume original and scaled-up auxetic cubes. Finally, dome-shaped auxetic
implants, with dimensions of 100 mm bottom diameter and 50 mm height, infilled with hydrogel
containing adipose tissue segments, will be implanted into the abdominal cavity of Yucatan
swine for 1 month. Adipose tissue regeneration will be assessed through histological and
immunochemical analysis.

Public health relevance
Project Narrative This project proposes to test the hypothesis that scaling up the auxetic design by increasing strut width and consequent struct interval will further enhance its structural, mechanical, and biological performance. The structural and mechanical performance, including flexibility, durability, and permeability, of the scaled-up auxetic design will be assessed in comparison with the original design through finite element (FE) simulation, µCT analysis, mechanical tests. In addition, the biological performance of the scaled-up auxetic design, including cell viability, activation, and tissue regeneration capacity, will be assessed in comparison with the original design through in vitro, and in vivo pre-clinical examinations.